Exploring the Impact of Base Deaminase Deregulation on Precancer Evolution

PROJECT SUMMARY
Recent research suggests that primate-specific APOBEC3C-mediated C-to-T DNA and ADAR1-mediated A-to-
I RNA editing represent essential drivers of human cancer progression. Though many DNA and RNA editing
sites have been identified, the functional relevance of APOBEC3C and ADAR1 deaminase deregulation,
especially in primary patient samples, is still unresolved. By elucidating the relative roles of APOBEC3C and
ADAR1 in myeloproliferative neoplasm (MPN) progression to secondary acute myeloid leukemia (sAML), this
represents a unique opportunity to understand how DNA and RNA editing deregulation drive cancer stem cell
generation and therapeutic resistance. While pro-inflammatory cytokine-responsive ADAR1 (adenosine
deaminase acting on RNA 1) and APOBEC3 (apolipoprotein B mRNA editing enzyme, catalytic polypeptide like
type 3) base deaminases restrict viral replication5 and LINE element retrotransposition, base deaminase
deregulation has been linked to both genomic and epitranscriptomic (post-transcriptional modification) instability.
We have shown that pro-inflammatory cytokines activate primate specific APOBEC3C-mediated cytidine to
thymidine (C-to-T) deamination of DNA and ADAR1 p150 isoform-mediated adenosine to inosine (A-to-I)
deamination of double-stranded RNA (dsRNA) thereby fueling transformation of pre-LSCs to LSCs in
myeloproliferative neoplasms (MPN). The overall goal of this proposal is to continue our investigation of
malignant deaminase activation in directing human pre-LSC evolution to sAML LSCs with the ultimate aim of
informing the development of effective strategies that predict and prevent transformation to rapidly fatal
sAML. We will investigate if ADAR1 shRNA knockdown reduces telomere length, TERT expression and alters
the self-renewal program in pre-LSCs and LSCs in stromal co-cultures and humanized mouse models. In Aim 2,
we proposed to examine the detailed mechanisms of how ADAR1 drives WNT/beta-catenin signaling in primary
patient samples in stromal co-cultures and humanized mouse models as well as reporter and confocal
fluorescent microscopy. Lastly, we will test if activation of both APOBEC3C and ADAR1p150 fuels pre-LSC
evolution by whole genome sequencing, Tapestri single cell DNA, and proteomic sequencing platform. In
addition to vastly expanding our knowledge of A-to-I editing function in progenitor cell maintenance, this research
program will inform the development of malignant ADAR1 editase detection and inhibition strategies that may
help to prevent progression of MPNs to acute myeloid leukemia.

Public health relevance
PROJECT NARRATIVE In 295,000 individuals in the US who are living with myeloproliferative neoplasms (MPNs), progression to therapy resistant secondary acute myeloid leukemia (sAML) remains a major cause of morbidity and mortality as well as growing healthcare economic burden thereby underscoring the pressing unmet medical need for predicting and preventing MPN progression. Recently, we discovered that inflammatory cytokine-induced activation of APOBEC3C and ADAR1p150 base deaminases fuels hematopoietic stem and progenitor cell (HSPC) proliferation during leukemic transformation of MPNs. Thus, the overarching goal of this project is to elucidate the APOBEC3C-mediated DNA and ADAR1p150-mediated RNA editing mechanisms governing MPN HSPC reprogramming into long-lived, self-renewing leukemia stem cells (LSC) with the ultimate aim of informing the development of strategies that predict and prevent sAML transformation.